Targeting a reductive dehalogenase as a new strategy for controlling mosquito populations

ABSTRACT
Targeting a reductive dehalogenase as a new strategy for controlling mosquito populations
The enzyme iodotyrosine deiodinase gained prominence from its role in salvaging iodide
from iodotyrosine. This activity is necessary for generating the iodinated hormone
thyroxine that is required for all vertebrates. Surprisingly, this enzyme was also found
nearly ubiquitous in invertebrates that do not require iodide nor generate thyroxine. Initial
studies have suggested that its ability to process a range of halotyrosines (X = I, Br, Cl, not
F) remains the same in fruit flies, but its biological role is quite different. The dehalogenase
protects flies from the accumulation of endogenous halotyrosine that would otherwise
suppress male fertility. Inhibition of the dehalogenase or accumulation of a halotyrosine in
vivo significantly decreases fly populations by a mechanism orthogonal to those currently
used to mitigate vector-borne disease. Homologs of the dehalogenase are present in most
insects and offer a new and potent target for eliminating such vectors if the results from fruit
flies extend to other invertebrates.
The Anopheles gambiae mosquito was selected as the test organism in our investigations
due to its importance as a vector of malaria. Despite a vast amount of research and field
work, this disease remains a health priority and its return has recently been reported in the
United States. Knowledge gained from fruit flies now guides our experiments on the
mosquito. Loss of fertility will be examined after alternative external exposure to
halotyrosines and internal suppression of the dehalogenase by chemical and genetic
strategies. Analytical chemistry will identify which halotyrosine is generated endogenously
and whether halogenation targets tyrosine free in solution or tyrosyl residues within
proteins. Initial efforts are also planned to identify the peroxidase responsible for
halogenation to build a foundation for broad investigations in the future on the nature and
function of an overlooked cycle of halogenation and dehalogenation in insects. The most
immediate impact of these studies will derive from a newfound ability to limit mosquito
populations and the diseases that they spread.

Public health relevance
Project Narrative The orphan enzyme of interest was recently associated with male fertility in fruit flies and now presents a new target for controlling insect populations. The generality of this observation will be tested with mosquitoes that transmit malaria. Knowledge gained on this class of enzymes may ultimately provide a common strategy for eradicating a wide range of insects that negatively affect human health.